Regulation of Hedgehog Signaling by new cilium proteins

PROJECT SUMMARY
Hedgehog (Hh) signaling is widely involved in development and cancers, including medulloblastoma
(MB), the malignant pediatric brain tumor. Current treatment regimens bring life-long devastating side effects to
survivors, generating a huge burden to the patients’ family. The current Hh pathway inhibitors are challenged
by drug resistance and tumor relapse. We aim to understand the basic transduction mechanisms of the Hh
pathway in order to provide new clues to treat Hh-related cancers. This proposal is based on my previous
discovery that PDE4D controls local PKA activity at specific subcellular sites to regulate Hh signaling. In the
past two years of this grant, we have studied the control of Hh signaling by local PDE4D-PKA at the
centrosome. We found that 1) PDE4D3 is anchored to the centrosome by myomegalin to locally inhibit PKA
activity, 2) knocking out myomegalin with shRNA or CRISPR/Cas9 specifically increases PKA activity at the
centrosome, and 3) this selectively inhibits Hh signaling without interfering other PKA-related cellular events.
Based on the exciting results and the innovative tools we have built, in the current proposal we will expand our
research to systemically investigate the regulation of Hh signaling by local PKA in the cilium. We will 1) define
the signaling mechanism from Smo to PKA in the cilium, a mysterious step in the Hh pathway; 2) determine the
effects of selectively promoting ciliary PKA on Hh signaling and Hh-related tumor growth; and 3) identify the
signaling transducers associated with Smo via proximity labeling-based proteomics to thoroughly illuminate its
downstream signaling cascade during Hh transduction. Our approach is innovative because it combines cutting
edge techniques to elucidate the long-standing questions in the Hh pathway. Its significance is underlined by
the expectation that it will highlight new approaches to treat pediatric brain tumor with fewer side effects.
Equally importantly, this research funding will allow me to engage first generation college students in
biomedical research at UC Merced to diversify and strengthen academic research in the economically deprived
California Central valley.

Public health relevance
PROJECT NARRATIVE: The Hedgehog (Hh) pathway is responsible for a variety of human tumors, including medulloblastoma, the most common pediatric brain tumor. Current treatment regimens for Hh-related tumors are not ideal due to the associated devastating side effects and drug resistance, calling for new targets to inhibit the Hh pathway. We harness most recent progresses in the field of Hh signaling to gain mechanistic insights about this Hh pathway regulation which will pave the way to the development of new Hh-pathway inhibitors with fewer side effects.